Human Health Exposure Analysis Resource (HHEAR): Coordinating Center

PROJECT SUMMARY/ABSTRACT
The National Institute of Environmental Health Sciences (NIEHS) is establishing an infrastructure, the Human
Health Exposure Analysis Resource (HHEAR), to provide the extramural research community access to
laboratory and statistical analyses to add or expand the inclusion of environmental exposures in their research.
HHEAR will be composed of three components: a Coordinating Center (CC), a National Exposure Assessment
Laboratory Network, and an Exposure Data Repository and Resource for Statistical Analysis and Methods
Development. This project will implement the CC for HHEAR. HHEAR will provide a range of sophisticated
laboratory analyses and data services to the exposure science and health research community. The main goal
of the CC is to provide researchers with a convenient and unified interface to access the available services of
this complex network. The CC will (1) create and maintain a comprehensive index of HHEAR laboratory and
data services, methodologies, and expertise available to researchers; (2) provide a public website as the
primary means for researchers to access information about HHEAR’s capabilities and initiate proposals to use
HHEAR’s resources; (3) establish and manage processes for proposal submission and evaluation; (4) monitor
the progress of approved proposals and track services workflow; (5) define the quality standards by which the
performance of HHEAR will be measured; (6) support the standardization of laboratory analyses and
processes; (7) organize and support HHEAR oversight committees; (8) manage a Pilot and Feasibility
Program; (9) develop and implement a strategic communication plan for HHEAR; (10) identify external
resources of interest to exposure science and health research; and (11) leverage the HHEAR public website
and social media to promote HHEAR’s available resources and accomplishments to the broader scientific
community.

Public health relevance
PROJECT NARRATIVE This project will coordinate the activities of several institutions that will provide sophisticated laboratory and data analysis capabilities that will work together to advance our understanding of the effect of environmental exposures on health across the human life course.